Promoting Recreation Time among Individuals Incarcerated in Jail

PROJECT SUMMARY
More than 9 million Americans are incarcerated in jail each year. Of these individuals, 60% are racial/ethnic
minorities and are from socioeconomic disadvantaged populations. Among individuals incarcerated in a rural,
county jail, there are high rates of anxiety, hypertension, and poor sleep quality while incarcerated. Physical
activity (PA) can mitigate these outcomes and be immediate. A single bout of moderate-to-vigorous PA improves
anxiety symptoms, decreases blood pressure, and improves sleep on the day it is performed. Despite these
benefits, over 75% of individuals incarcerated in jail do not attend recreation time (rec-time), a structured time
dedicated for PA. Of those who attended rec-time, over half were sedentary and no interventions have been
conducted in the jail setting to promote PA. The scientific objective of the proposed research is to develop and
test the feasibility and preliminary impact of a robust physical activity program among individuals while
incarcerated in jail. We hypothesize that individuals residing in housing units assigned to the intervention arm
will have higher rec-time attendance, PA levels, self-efficacy, expectations and values of PA, perceived behavior
of others, sleep quality, as well as lower stress, anxiety, and depression symptoms as compared to individuals
residing in housing units assigned to the control arm. We will identify essential theoretical constructs of Social
Cognitive Theory (SCT, i.e., self-efficacy, social support, self-regulation, behavioral capability, outcome
expectations, environment), as well as behavioral and cultural attributes of PA among individuals incarcerated
to enhance the cultural relevance and effectiveness of a PA program through focus groups and key informant
interviews. From formative research, input from jail administration on feasibility of implementation, and
involvement from individuals incarcerated on acceptability, we will develop a robust PA program to promote rec-
time attendance and increase PA among individuals incarcerated. Once developed, we will determine feasibility
preliminary impact of a PA program using a two-armed clustered randomized control trial to randomize 18
housing units to either an intervention or control arm. Study outcomes include rec-time attendance, PA levels at
rec-time, self-efficacy, expectations and values of PA, perceived behavior of others, sleep quality, stress, anxiety,
and depression. The potential individual gains from even one bout of PA are substantial. Providing individuals
opportunities to attend and be physically active during rec-time may improve health conditions in correctional
institutions. This research plan is complemented by a training plan that builds on the applicant’s background in
epidemiology that includes new training in (1) qualitative and mixed methods, (2) intervention development,
implementation, and evaluation, and (3) clinical trials. The combined research and training plans will prepare the
applicant for a successful, independent research career focused on identifying approaches to promote PA and
reduce related health disparities among incarcerated populations.

Public health relevance
PROJECT NARRATIVE The purpose of this study is to develop and test the feasibility and preliminary impact of a robust physical activity program among individuals while incarcerated in jail. Based in Social Cognitive Theory and through focus groups and key informant interviews, we will identify theoretical constructs and attributes of physical activity among individuals incarcerated. From formative research, we will develop and evaluate the feasibility and preliminary evidence of impact (Social Cognitive Theory constructs, sleep quality, stress, anxiety symptoms, and depression symptoms) of a physical activity program among individuals incarcerated in jail using a pilot clustered randomized control trial.